Pericyte control of capillary perfusion in the Alzheimer's disease brain

In Alzheimer's disease and Alzheimer's disease related dementias (AD/ADRD), aberrant contraction of capillary
pericytes contributes to cerebral hypoperfusion. However, our understanding of the vasoactive signals and
intracellular mechanisms underlying pericyte contractility remains lacking. Pericytes express high levels of
endothelin-1 type A receptors (ETAR) and thromboxane A2 receptors (TXA2R). Our central hypothesis is that
ETAR and TXA2R signaling is essential to optimize blood flow through brain capillary networks, and that aberrant
activity through these receptors during amyloid beta (A) accumulation contributes to hypoperfusion. To address
this hypothesis, we will use an in vivo-ex vivo pipeline with innovative imaging approaches and a novel murine
Cre-driver to genetically target CNS pericytes. The work will be conducted by investigators with complementary
expertise in in vivo two-photon imaging of blood flow, ex vivo brain slice experiments, pericyte biology, and ETAR
and TXA2R signaling mechanisms. Aim 1 will test the hypothesis that ETAR and TXA2R signaling in pericytes
provides basal capillary tone and orchestrates optimization of flow through brain capillary networks. ETAR (ednra
gene), and separately, TXA2R (tbxa2r gene), will be conditionally deleted in capillary pericytes of normal mice.
In vivo deep two-photon imaging will be used to study capillary flow dynamics across cortical layers and into
callosal white matter of awake mice. A battery of vascular metrics, tissue hypoxia, neuroinflammation, and
behavioral outcomes will be assessed. Aim 2 will test the hypothesis that G-protein signaling downstream of
ETAR and TXA2R requires actomyosin contractile machinery in capillary pericytes, despite low expression of α-
smooth muscle actin. We will use chemogenetics to drive G-protein activation, as seen downstream of ETAR
and TXA2R signaling. Pericytes will be chemogenetically contracted in ex vivo brain slices and blockers of
actomyosin and cytoskeletal machinery will be administered to dissect their roles in pericyte contraction. Further,
chemogenetic activation of CNS capillary pericytes in vivo will be characterized as a new model of cerebral
hypoperfusion. Aim 3 will test the hypothesis that aberrant ETAR and TXA2R signaling drives deficiency in
capillary perfusion and cognitive decline during A accumulation. Conditional genetic deletion of ETAR or
TXA2R, and separately, chronic administration of ETAR/TXA2R inhibitors will be examined in two models of AD-
like pathology (Tg-SwDi and 5xFAD). Effects on cerebral blood flow, brain health, and behavioral metrics will be
examined. This project will advance our understanding of brain hypoperfusion in AD/ADRD by: (1) Deciphering
mechanisms of pericyte contractility in the normal and AD brain; (2) leveraging a novel capillary pericyte-specific
mouse line to dissect pericyte contributions to blood flow; (3) characterizing a novel model of capillary-driven
hypoperfusion in vivo; (4) employing advanced in vivo imaging approaches to study deep capillary networks
most strongly affected in AD/ADRD; (5) providing proof of concept preclinical studies to test if modulation of
ETAR and TXA2R signaling in pericytes can improve capillary network flow and cognition in AD/ADRD.

Public health relevance
Project Narrative Blood flow through the brain capillaries is impaired in Alzheimer’s disease, and preclinical research is needed to understand the bases for this impairment and to identify therapeutic avenues to improve capillary flow. This project will use cutting-edge microscopy and genetic approaches in live mice to study pericytes, a cell type that regulates capillary blood flow, and determine how contractile signals to these cells contributes to normal blood flow and reduced blood flow in models of Alzheimer’s disease-like pathology.